Deconstructing pineoblastoma origins to advance disease biology, modeling, and therapy

Pineoblastoma (PB) is an understudied, clinically aggressive embryonal tumor of the pineal gland diagnosed
early in life. Due to its rarity, knowledge pertaining to the molecular and cellular basis of PB has remained modest.
Likewise, preclinical models of PB are extremely scarce, stalling efforts to discover and credential curative
therapies that reduce collateral damage to the developing central nervous system. To overcome the primitive
understanding of PB tumor biology and identify clinically relevant molecular heterogeneity, we recently performed
bulk genetic, epigenetic, and transcriptional profiling on a sizable cohort of primary patient tumor samples,
defining four distinct subgroups: PB-RB1, PB-MYC/FOXR2, PB-miRNA1, and PB-miRNA2. Namesake PB-RB1
and PB-MYC/FOXR2 subgroups represent the primary diagnoses of PB during infancy and account for an
unacceptably high mortality rate. Loss-of-function mutations targeting miRNA processing genes define the
clinically heterogeneous PB-miRNA1 and PB-miRNA2 subgroups diagnosed in children and adolescents. An
international consensus on the definition of these novel PB subgroups was included in the most recent update
to the World Health Organization (WHO) Classification of Tumours of the Central Nervous System and has
begun to change how PB is diagnosed clinically. In this research program, we aim to advance understanding of
biologically and clinically distinct PB subgroups through deep investigation of their cellular, developmental, and
pathological basis. We hypothesize that molecular subgroups of PB exhibit divergent cellular programs and
originate from discrete progenitor states during pineal gland development. Disclosing cellular hierarchies and
developmental origins of novel PB subgroups will (i) resolve oncogenic mechanisms; (ii) inform preclinical
modeling strategies; (iii) implicate candidate dependencies; and (iv) enable evaluation of novel therapeutic
strategies. This hypothesis will be tested in two conceptually and technically innovative Specific Aims that
integrate a multidisciplinary and multispecies approach. In Aim #1, we will leverage a large single-nucleus
transcriptome dataset generated from molecularly annotated PB patient tumors to discover cellular programs
driving malignancy. In addition, we will utilize first-in-class atlases of the developing mouse and human pineal
gland to define subgroup-specific cellular origins and reveal tumor-enriched molecular signatures, collectively
informing pathogenic mechanisms and candidate therapeutic vulnerabilities. In Aim #2, we will deliver a series
of novel, genetically engineered mouse (GEM) models representative of distinct PB subgroups, including
comprehensive phenotypic and molecular characterization. Novel GEM models will validate suspected PB driver
genes and serve as essential preclinical models for testing innovative treatment strategies targeting prominent
cell identity programs. Successful execution of this research program will overcome essential knowledge gaps
pertinent to biological and clinical heterogeneity in PB and provide a platform for the pursuit of more specific,
less toxic treatment options for affected patients.

Public health relevance
Pineoblastoma (PB) is a poorly understood malignant embryonal tumor of the pineal gland for which safer and more effective therapies are urgently needed. Applying multi-omic analyses to a large international cohort of bulk PB tumor specimens, we recently identified four distinct molecular subgroups of PB, each characterized by discriminatory genetics, demographics, and clinical outcomes. This multidisciplinary proposal seeks to deconstruct the cellular and developmental basis of novel PB subgroups, while producing biologically faithful preclinical models required to improve treatments and outcomes for affected children in the future.